Computational and experimental methods for scalable identification of oncogenic non-coding regions

Project Abstract
In this project, we will identify context-specific enhancers, whose activity is essential for either the
growth of primary tumors or for evolution of treatment-resistance in metastatic tumors by
modulation of target gene expression. We will identify open chromatin sites in metastatic
treatment-resistant breast tumors using whole-genome sequencing of cell-free DNA. Cell-free
(cfDNA)
enzymatic
in plasma predominantly originates from nucleosome-protected parts of DNA after
processing. We will develop innovative computational methods that will analyze the
nucleosomal signal obtained from whole-genome sequencing of cfDNA from plasma of metastatic
cancer patients. We will develop scalable methods to create catalogues of `oncogenic' enhancers
that are essential for tumor growth, which may or may not be due to DNA sequence variants at
these regions. We will decipher the impact of subtype specific enhancer perturbation on tumor
initiation (using CRIPSRa) and continued growth (using CRISPRi) in primary breast cancers. We
will test the impact of repressing ~15,000 accessible sites in breast cancer on tumor growth in
pooled CRISPR screens in multiple cell lines for each major breast cancer subtype. Importantly,
we will also study the impact of activation of the same enhancers on tumor initiation in normal
(and malignant) breast cell lines, and we will identify `tumor-suppressive' enhancers that when
silenced drive tumor growth. We will also identify oncogenic mutations by integration of 4,427
breast cancer whole-genomes and CRISPR base editing screens. We will focus on specific
mutations at cis-regulatory elements, CREs (enhancers, promoters and untranslated regions).
For the top 5000 putative noncoding drivers, we will first insert precise mutations via base editing
and then, for the top 500 with the most dramatic impact on growth, we will use single-cell
sequencing coupled with base editing to decipher their impact on gene expression in cis and in
trans. We will also examine the interaction between the top noncoding drivers and aromatase
inhibitors, which is a therapy prescribed in many breast cancers.

Public health relevance
Project Narrative We will identify the non-protein-coding regions of the genome that play an important role in tumor initiation and growth by modulating the expression of protein-coding regions. We will develop innovative computational methods that will make it feasible to identify these regions in metastatic cancer patients using non-invasive liquid biopsies. We will use high-throughput CRISPR screens to understand the impact of perturbation of thousands of regions and also probe their roles in specific contexts, such as resistant to therapy in breast cancer patients.